Homologous recombination deficiency and beyond in pancreatic cancer: evaluating the regulators of response to pembrolizumab and olaparib (POLAR) from the immune and genomic perspectives

PROJECT SUMMARY – RP2
Pancreatic ductal adenocarcinoma (PDAC) is characterized by low tumor mutational burden, impaired antigen-
presentation, low levels of infiltrating cytotoxic CD8+ T cells, and a non-immunogenic tumor microenvironment –
collective features which contribute to immunotherapy-resistance. There is a need to identify sensitive patient
subgroups and effective immunotherapy combinations for PDAC. Recent studies suggest that poly-ADP ribose
polymerase inhibitors (PARPi) can enhance the efficacy of immune checkpoint blockade with programmed cell
death protein 1 (PD-1) blockade, potentially by enhancing tumor antigenicity and/or modulating the tumor
immune microenvironment. The PARPi olaparib is FDA-approved as a maintenance therapy in platinum-
sensitive germline BRCA-mutated (gBRCA-m) metastatic PDAC. Our group also reported a very high response
rate for gBRCA-m and gPALB2-m PDAC patients—which represents only 5-7% of PDAC—treated with platinum
in a phase 2 trial. Through a recent retrospective analysis (Park et al., CCR 2020), we identified that PDAC with
mutations in core homologous recombination (HR) genes (BRCA and PALB2) or non-core HR genes have
greater genomic instability and respond well to DNA damage response (DDR)-targeted agents (e.g., platinum or
PARPi), with a survival benefit, particularly when the HR gene had biallelic loss. Surprisingly, certain patients
without known HR gene mutations had exceptional responses to DDR-targeted agents, indicating there may be
additional, unidentified biological indicators beyond canonical HR gene mutations, perhaps linked to tumor
genetics and/or immune features of the tumor microenvironment. We hypothesize that PARPi can render PDAC
immunogenic and sensitive to PD-1 blockade in a subgroup of patients with homologous recombination
deficiency (HRD) beyond traditionally defined gBRCA-m. To test this hypothesis, we designed a phase 2 trial to
evaluate antitumor activity of pembrolizumab and olaparib (POLAR) in metastatic PDAC patients with HRD
(canonical BRCA or other HR genes) and in patients with exceptional platinum response but no HR gene
mutations. In this SPORE Research Project, we will use serial biospecimens acquired from POLAR trial patients
to understand the tumor genetics and features of the host and tumor immune ecosystem associated with
radiographic POLAR responses and resistance. We will use a combination of sophisticated genomic, single-cell
transcriptomic, and computational methods to: (1) determine mutational signatures that distinguish POLAR
response and functional consequences, (2) characterize cellular biomarkers, including tumor sub-populations,
immune infiltrates, and tumor microenvironment features associated with POLAR response, and (3) investigate
if POLAR boosts tumor neoantigenicity. We expect to identify underlying factors that differentiate responders
and non-responders and provide insights into the biologic mechanisms of response and resistance to a PARPi-
immunotherapy combinations that can guide future precision immunogenomic strategies to treat advanced
PDAC and inform opportunities for patient selection beyond those with HR gene mutations for relevant therapies.

Public health relevance
NARRATIVE – RP2 Current immunotherapies are ineffective for the vast majority of patients with pancreas cancer, and novel approaches are needed to harness the role of immunotherapy in this disease. Emerging evidence suggests poly- ADP ribose polymerase inhibitors (PARPi) can render pancreas cancer immunogenic and improve response to immune checkpoint blockade in a subgroup of patients with homologous repair deficiency (HRD). An improved understanding of the tumor genetics and immunologic features that contribute to response and resistance to this therapeutic combination will guide precision immunogenomic strategies to improve outcomes for patients with pancreas cancer, including beyond those with HRD.